Johns Hopkins Alzheimer's Disease Research Center

OVERALL – PROJECT SUMMARY/ ABSTRACT
The Johns Hopkins Alzheimer's Disease Research Center (JHADRC) is an integrated program of investigators
whose overarching goal is to improve understanding of the earliest phases of AD and to expand therapeutic
approaches. The overall scientific focus of the JHADRC is on the earliest stages of AD and related disorders in
humans and in model systems, through characterizing the earliest clinical and pathophysiological processes,
and by identifying cellular and molecular events that contribute to the abnormalities in model systems that
capture aspects of the human disorders. We also focus efforts on improving care of patients in the
symptomatic phases of disease. We have made substantial progress with these research goals during the
current funding cycle, supported by a P50 center grant, and propose to continue and expand this work in the
next funding cycle, through a P30 grant mechanism. The proposed Center consists of 6 Cores and one
component : (1) the Administrative Core (Core A), (2) the Clinical Core (Core B), (3) the Data Management and
Biostatistics Core (Core C), (4) the Neuropathology Core (Core D), (5) the Outreach, Recruitment and
Engagement Core (Core E), (6) the Biomarker Core (Core F) and (7) the Research Education Component
(REC). In this application we are also including funds for 3 Developmental Projects; we anticipate funding one
developmental project for 2 years and two developmental projects for 3 years each.

Public health relevance
OVERALL – PROJECT NARRATIVE The Johns Hopkins Alzheimer's Disease Research Center is an integrated program aimed at finding improved treatments for patients with Alzheimer disease and related disorders. Complimentary activities within the center include clinical and basic research studies that incorporate state-of-the art methodologies, and contribute significantly to national programs. We are dedicated to training the next generation of investigators and to reaching out to the community to improve understanding about these diseases.